Leica TCS SP8 STED3X

This application requests funds to purchase a Leica SP8 TCS STED 3X microscope to serve investigators at the Icahn School of Medicine at Mount Sinai and in New York City. The instrument will be housed and administered by the institution's Microscopy Core, a facility that has been in continuous operation for more than twenty-five years. The goal is to bring a critical research capability to nine Major Users and one Minor User in seven departments and supported by fifteen NIH grants as well as to make the technology available to other qualified users in the New York City area. The capabilities of the instrument are not duplicated by any on campus. Very few individual labs have the means to purchase, house and maintain their own super-resolution microscope and the Leica SP8 TCS STED 3X is an outstanding, flexible and user friendly instrument that will bring acquisition of high quality, high resolution data within reach of junior and senior investigators who rely on light microscopy to advance their science. The acquisition of the Leica SP8 TCS STED 3X at Mount Sinai will contribute directly to the advancement of several research initiatives that will further current understanding in several major areas relevant to human health including molecular and cell biological mechanisms of viral infection, bacteria-mediated inflammation, neurodegenerative disease, developmental brain disorders, vision, stress and depression. The research that will benefit covers a broad range of significant, unsolved questions central to the overall mission of NIH.

Public health relevance
This application requests funds to purchase a Leica SP8 TCS STED 3X microscope to serve investigators at the Icahn School of Medicine at Mount Sinai and in New York City. Acquisition of this instrument would contribute directly to the advancement of several research initiatives that will further current understanding in several major areas relevant to human health including mechanisms of viral infection, neurodegenerative disease, developmental brain disorders, vision, stress and depression.